Optimizing Telehealth to Improve Secondary Stroke Prevention

PROJECT SUMMARY/ABSTRACT
Stroke prevalence is predicted to reach 10 million by 2030, with the largest increase in Hispanic and Black
populations. About half of patients who survive a stroke are at increased risk of stroke recurrence within three
months, making this a critical period for preventative intervention. While hypertension is the most important
modifiable risk factor for stroke, blood pressure (BP) remains poorly controlled among many largely due to low
medication adherence and particularly among ethno-racial minorities. Additionally, physical activity (PA), which
is linked to lower BP, is low among patients following a stroke. There is evidence that behavioral and medical
interventions could reduce recurrent events by 80%, but such interventions are lacking, and real-world
application is limited. The goal of this proposal is to develop and test a scalable, patient-centered, telehealth-
delivered behavioral intervention that promotes self-regulation for multiple health behaviors, i.e., BP medication
adherence and PA.
I hypothesize that a theory-based behavioral intervention that increases allocated attention for enhanced
self-regulation can improve multiple preventive health behaviors. Using translational research models and an
optimization trial design, I will investigate the feasibility of an intervention that utilizes infographic-guided
motivational interviewing (MI) and self-monitoring with behavioral and environmental feedback during the first
three months following a stroke. In Aim 1, I will identify educational content in an MI intervention for BP control
and PA in post-stroke patients and culturally adapt it with input from local diverse stroke patients and their
professionally diverse providers. To support the adapted MI, infographics will be generated in English and
Spanish with patient's own data for automated delivery. In Aim 2, I will conduct a MOST (Multiphase Optimization
Strategy)-inspired pilot feasibility trial to identify feasible components for BP control, PA, or both. Finally, as an
Exploratory Aim, I will conduct a preliminary assessment of intervention efficacy and target health behavior
change mechanisms. A detailed understanding of how each component performs and impacts health behavior
will lead to more targeted patient-centered interventions while addressing inequities for improved health
outcomes. This work will also allow me to develop valuable expertise in behavioral interventions.
I have a clinical background in neurology with an emphasis on stroke and cerebrovascular diseases and
have a Master's degree in Patient Oriented Research. I am committed to a career in stroke prevention research
and plan to use the training obtained through this NIH Career Development Award to support my future work in
this field. With the long-term goal of independence as a physician-investigator with expertise in behavioral
interventions for stroke prevention, I have assembled a multidisciplinary mentoring team and set short-term goals
in biomedical informatics, behavioral intervention trial methods, and human centered design in health disparities
research.

Public health relevance
PROJECT NARRATIVE Blood pressure control and physical activity in the first months after a stroke are known to reduce the risk of a second stroke and improve recovery, but effective interventions and strategies to promote these factors are lacking, particularly for ethno-racial minorities. We hypothesize that repetitive learning through self-monitoring and motivational feedback with patient-tailored infographics can improve these preventive health behaviors through enhanced self-regulation. Therefore, in alignment with the NINDS mission to reduce the burden of neurological disease for all people, we will develop and test a scalable patient-centered telehealth-delivered behavioral intervention for secondary stroke prevention in our underserved urban population.